CORTICOTROPIN RELEASING FACTOR (HCRF) EFFECTS AND POSSIBLE ROLE IN ADDICTIVE DIS

We are studying the effects of CRF on neuroendocrine responsivity and also on related immune responsivity, and thus possibly the related anti-inflammatory status, in normal volunteer subjects as well as in subjects with defined addictive diseases.